Investigating the role of DNA polymerase iota in the development of lung cancer

? DESCRIPTION (provided by applicant): Lung cancer is the leading cause of cancer-related deaths in the United States, and its incidence rate is largely attributed to inhalation of tobacco smoke. Tobacco smoke is traditionally composed of a potent cocktail of over 5000 chemicals, many of which are mutagenic and carcinogenic. Urethane, one compound found in cigarette smoke, is metabolized by cytochrome P450 enzymes to yield a highly reactive epoxide intermediate that can bind DNA and cause adduct formation. As a result, urethane is highly carcinogenic and a model compound for tumor induction in laboratory animals, especially lung tumor formation. Previous studies demonstrated that mice exposed to urethane can be categorized as sensitive, intermediate, or resistant to pulmonary adenoma formation, with resistance to lung tumorigenesis attributed to a locus on chromosome 18 identified as pulmonary adenoma resistance 2 (Par2). Interestingly, the Par2 interval contains the gene for Polι, a Y-family DNA polymerase involved in lesion bypass. Further studies identified that Polι may be a candidate for the Par2 locus, and we hypothesize it could play a role in the protection against lung tumorigenesis via error-free replication of damaged DNA induced by environmental genotoxins. We will test this hypothesis using in vitro and cellular replication assays to determine the accuracy and efficiency with which Polι bypasses the major DNA adducts produced upon urethane exposure. To monitor Polι's function at the organismal level, a knock-in mouse with catalytically inactive Polι will be employed to determine whether the sole presence of Polι or its lesion bypass function is responsible for protecting against lung tumorigenesis. Th outcome of this proposed research will be instrumental in determining the elusive cellular role for Polι, and could prove useful in the development of future lung cancer therapeutics.

Public health relevance
PUBLIC HEALTH RELEVANCE: Lung cancer is the leading cause of death in the United States, and largely stems from the inhalation of tobacco smoke. It has been shown the polymerase ι (Polι) may protect against the development of lung cancer. This research seeks to identify how Polι may protect against lung tumor development at a molecular, cellular, and organismal level, which could be used in the development of more successful lung cancer therapeutics.